CUped: An Approach to Motor Recovery Post-Stroke, not Compensation

Project Summary
The goal of lower limb rehabilitation after stroke is recovery of independent walking at home and in the
community. Few stroke survivors achieve this goal. Suboptimal outcomes are due to the serious and
intransigent nature of movement impairments caused by stroke and the scarcity of feasible and effective
therapies that restore movement lost to stroke.
Our team has developed a novel exercise intervention called CUped (pronounced cupid, like the Roman god)
to address barriers to recovery and improve walking after stroke. CUped is so called because it compels use of
the paretic limb during a movement that resembles pedaling. This project will examine safety, acceptability,
and tolerance to CUped, characterize its therapeutic effects, and identify dose-response relationships. Results
will provide preliminary data for an R01 to support a randomized controlled trial (RCT).
CUped is designed to help stroke survivors recover lower limb movement lost to stroke, thereby improving
walking. It is intended to be used as an adjunct to gait training. CUped uses a robotic technology that
eliminates compensatory movements that interfere with recovery, compels use of the paretic lower limb, and
targets 3 key movement impairments caused by stroke: decreased muscle output from the paretic limb,
inappropriate paretic muscle timing, and abnormal interlimb coordination. Exercise is done in sitting which
enables high repetition practice. Like walking, CUped requires continuous, reciprocal use of both lower limbs;
effects are likely to transfer to walking.
The risk-reward profile of this proposal is ideal for an R21, which is an NIH funding opportunity intended to
encourage exploratory/developmental research by providing support for the early and conceptual stages of
project development. CUped is a novel therapy grounded in a physiologic premise and based on prior
observations from our laboratory. We have pilot data suggesting that CUped fulfills its design specifications,
and this study will be the first to test its therapeutic effects. In this Stage 1 rehabilitation trial, we will support or
quickly refute the hypothesis that CUped is safe, acceptable, and capable of eliciting a therapeutic response in
stroke survivors. We will also examine tolerance to CUped and dose-response effects. If our hypotheses are
supported, we will be poised to run an RCT to isolate the effects of CUped and compare them to standard
care. Future work will investigate physiologic mechanisms underlying the effects of CUped.

Public health relevance
Project Narrative The goal of lower limb rehabilitation after stroke is restoration of independent walking at home and in the community. Few stroke survivors achieve this goal. This project proposes a Stage 1 rehabilitation trial to examine the safety, acceptability, tolerance, therapeutic effects of a novel exercise intervention designed to overcome barriers to recovery and improve walking after stroke.